Genomics-Bioinformatics Core

PROJECT SUMMARY
The ability to probe gene expression and chromatin landscape globally and at a single cell level has
opened the door to seek unprecedented information and insight into the development, homeostasis, repair, and
pathogenesis of skin as a complex organ. UC Irvine enjoys more than a critical mass of skin biologists with well-
established research expertise and programs that aim at understanding the regulatory mechanisms underlying
the biology of epidermal, dermal, pigment and vascular cells in skin, and how such mechanisms may go awry in
diseases such as psoriasis and skin cancer. While these skin biologists all have access to general genomics
techniques currently available on campus, there is an urgent need to adapt and develop unique and innovative
techniques and services that are tailored to skin biology in order to speed up the process of scientific discoveries.
The goal of the Genomics and Bioinformatics Core is to serve as a critical resource component of the Skin Center
to place its member investigators at the cutting edge of new genomics and bioinformatics developments. The
Core will leverage existing campus resources, such as technological instrumentation as well as genomics and
bioinformatics expertise at both faculty and researcher levels, to develop new skin-specific services and provide
technical and intellectual support to Center laboratories. The first specific aim of the Core is to provide state-of-
the-art genomics technologies for gene expression and epigenome profiling (e.g., Illumina RNA-seq, NanoString
nCounter, ATAC-seq, and ChIP-seq) along with dedicated staff time and associated statistical analyses (using
both commercial and customized pipelines) to advance skin research. The second specific aim is to promote
innovation in single cell analysis to foster understanding of cellular heterogeneities, differentiation hierarchies,
and cell-cell interactions in skin, for example by testing and applying new instrumentation and technologies for
single cell manipulation, developing new lineage-predicting bioinformatics tools for single cell data, as well as
establishing and improving multiplexed in situ RNA detection to create spatial maps of gene expression and cell
types or cellular states in the skin tissue. The third specific aim is to maintain a repository of all Center-generated
skin sequencing data and create publically accessible databases, such as a new website containing single cell
data with temporal and spatial information that is available to the skin research community at large. The last
specific aim is to provide organized activities (e.g., seminars, workshops, mini-courses) as well as one-on-one
consultation to train and educate Center skin biologists on basic genomics and bioinformatics. Collectively, these
aims will make significant and long-lasting impact on skin research at UC Irvine to not only facilitate important
scientific discoveries but also cultivate next-generation skin scientists with proficiency in genomics and
bioinformatics.